Regulation of Hepatobiliary Bile Acid Homeostasis in Neonatal Obstructive Cholestasis

PROJECT SUMMARY
Biliary atresia (BA) results in severe disruption of bile acid homeostasis and is the predominant disease causing
neonatal obstructive cholestasis. Bile acid homeostasis in regulated by the nuclear hormone receptor Farnesoid
X Receptor (FXR) by activation of the intestinal and hepatic hormone, fibroblast growth factor 19 (FGF19).
FGF19 suppresses bile acid synthesis of hepatic cytochrome P450 7a1 (Cyp7a1), the key enzyme for classical
bile acid synthesis. In healthy infants, the FGF19 expression is mainly in the intestine and low in the liver. In
contrast, hepatic FGF19 is elevated in BA infants to compensate for loss of intestinal bile acid-induced FGF19
secretion. The increase in hepatic FGF19 and bile acid accumulation in BA infants suggests an uncoupling of
FGF19 signaling that normally suppresses hepatic Cyp7a1 and bile acid synthesis. A secondary source of bile
acid synthesis in hepatocytes and cholangiocytes is the alternative pathway via Cyp27a1. There is a gap in our
knowledge of how the regulation of Cyp7a1 and Cyp27a1 via FXR-FGF19 signaling contributes to bile acid
homeostasis during neonatal obstructive cholestasis. This proposal aims to understand the adaptive, time-
dependent mechanism by which the liver compensates for altered intestinal bile acid signaling and how this
compensation effects bile acid synthesis via the classical and alternative pathways. Our central hypothesis is
that hepatic adaptation to obstructive cholestasis leads to increased hepatocyte FXR-FGF19 signaling, but with
impaired suppression of Cyp7a1 or compensation by Cyp27a1 to sustain bile acid accumulation. In Aim 1a we
will characterize the ontogeny of cholestatic liver injury, bile acid homeostasis, and cell-specific hepatocyte and
cholangiocyte gene expression signatures in a newly developed neonatal pig model of bile duct ligation (BDL).
In Aim 1b, we will quantify the molecular mechanisms of FXR and FGF19 signaling pathways involved in bile
acid synthesis during long-term bile acid exposure using human cultured hepatocyte and cholangiocyte
organoids. In Aim 2a, we will test whether FGF19 infusion dose-dependently suppresses Cyp7a1 expression at
early and late time points after BDL. In Aim 2b, we will test if early activation of FXR-FGF19 signaling protects
against BDL induced cholestasis. This study will provide understanding of the mechanism that regulate bile acid
homeostasis in the context of neonatal obstructive cholestasis and test potential therapeutic interventions.
Career development and environment: To enhance my potential for future success as an independent
researcher I will receive mentorship from Dr. Douglas Burrin, PhD and training in use of stable isotope kinetics
modeling, mass spectrometry analysis, RNA-seq pipeline analysis and visualization, and hepatic organoid
culturing. This training will be conducted in an outstanding research environment of the Children’s Nutrition
Research Center (CNRC) with support of NIDDK Digestive Disease Center technical cores and an expert faculty
oversight committee at Baylor College of Medicine. This project will give me the scientific expertise and research
skills to launch an independent research career in the field of pediatric liver diseases.

Public health relevance
PROJECT NARRATIVE During neonatal obstructive cholestasis, bile acids accumulate in the liver and blood through both impaired clearance and impaired suppression of synthesis. Our research will use a translational model of preterm piglets with bile duct ligation to examine the time-dependent adaptation of the liver to bile acid signaling, as well as, the contribution of classical and alternative bile acid synthesis pathways to determine which molecular targets are impaired. This research has important clinical relevance for the identification of pathways that may be targeted by pharmaceuticals to reduce liver injury that occurs during neonatal obstructive cholestasis from bile acids.